REGULATION OF A SLOW INHIBITORY SYNAPTIC EVENT

The long-term goal of this project is to understand how neurons of the cerebral cortex of mammals including ourselves communicate with each other by means of synaptic inhibition, in the belief that such basic understanding will lead to pharmacological tools that will therapeutically enhance or suppress such inhibitory processes in pathological conditions such as certain of the epilepsies. To approach this goal, we have examined in depth a non-classic form of inhibition that, unlike the more classic type, is mediated by GABA/b receptors that are coupled to potassium channels via pertussis toxin-sensitive G- proteins. Thin project will attempt to specify the particular G-protein that controls the conductance of this inhibitory response, the late IPSP. To this end, a transgenic mouse defective in one of the two primary candidate molecules for this function (G-alpha-i2) will be examined using intracellular recording techniques. Complementary studies propose to acutely remove one or more specific G-proteins by exposing brain neurons to synthetic oligo(deoxy)nucleotides that hybridize with messenger RNA, leading to the disappearance of the protein normally produced by that RNA. We have recently discovered two new sites that regulate the receptor class (GABA/b, receptors) that is responsible for the late lPSP in hippocampus: l) binding sites for calcium channel ligands; 2) receptors for ovarian steroid hormones. After further defining the latter site using ligand binding techniques, we propose to use intracellular and whole cell patch clamp techniques to find out whether either form of regulation is reflected in pre- or post-synaptic activity that depends upon GABA, receptors.